A multi-level framework for characterizing task-efficient coding geometry of neural population activities

We propose a multi-scale (from neurons to regions) theory that enables us to analyze neural computations from large sets of neurons engaging in a variety of simple to complex tasks. Advances in recording techniques in neuroscience have enabled simultaneous recordings of a large number of neural activities, providing greater access to signals in the brain, but also presenting a challenge in analyzing these high-dimensional neural activities in an interpretable way. Recently, we have developed a theoretical framework, which we call the Manifold Capacity Theory (MCT) framework, to analytically connect the geometric structure of neural activities to the capacity of a task-implementing readout. This work provides a new theoretical framework and data analysis algorithms to measure the efficiency of neural population data on representing the stimuli invariantly, and on implementing a given task. In Aim 1, we will use the MCT framework to characterize how properties of single neuron tuning curves collectively shape the geometry of neural manifolds. In particular we will focus on properties such as the number of tuning curves, and the maximum firing rate of tuning curves, as well as distribution properties such as tuning heterogeneity. Next, in Aim 2, by utilizing machine-learning based neural network modeling methods and new geometrical analysis framework, we will develop a new modeling paradigm ideal for answering how neural representations become transformed across brain regions or layers of the circuit hierarchy, and across acquisition of a task, both in biological brains and neural network models. Our preliminary analysis shows that geometric frameworks can produce population-level hypotheses on different mechanisms employed by different network architectures and employed by acquisition of a task. Finally, in Aim 3, we utilize measures from Manifold Capacity Theory as design principles for developing artificial neural network models of the brain. Combined together, these studies will lay groundwork for using geometrical frameworks and machine learning tools for (1) describing high-dimensional neural data across multiple spatial and temporal scales, (2) testing hypothesis on geometric mechanisms underlying neural circuit motifs and learning rules in shaping manifold representations, and (3) building novel algorithms for generating brain models and machine-generated hypotheses. In summary, the goals of this proposal are to develop a new class of multi-level framework for analyzing neural representations, by connecting single-neuron structure to population-level geometry to task- level efficiency and validate the new geometric tools using machine-learning generated neural network models as a testbed and hypothesis generator. Accomplishing these goals will lead to new theoretical principles and computational analysis paradigms that can be generalized across multiple spatiotemporal scales, across different modalities and brain regions. This in turn can lead to widely applicable quantitative tools in the broader neuroscience community, for understanding the neuronal basis of implementing behavioral and cognitive tasks in animals and humans

Public health relevance
Rapid progress in experimental neuroscience techniques and machine learning-based models for the brain presents a common challenge in understanding high-dimensional (many neurons) neural representations in an interpretable and quantifiable way. This proposal represents a path to a multi-level framework for connecting neural representational geometry to multiple scales (neurons to regions) and levels of computational abstraction, such as (i) the effect of single neuron tuning properties on neural representations, (ii) the role of region-to-region transformations and task-learning, and (iii) new algorithms for training neural network models of the brain via geometry and machine learning. The synergy between two modern approaches – task-efficient representational geometry and machine learning – will lead to new fundamental principles and methods in computational neuroscience and enable multi-level, multi-scale theory of neural representations and discover common principles of neural computation across different brain regions and multiple modalities.